Sensory cortical control of movement in health and disease

The spinal cord houses the neuronal networks responsible for executing various motor tasks involved in
locomotion. These spinal networks receive descending commands from the brain and brain stem. Spinal cord
injury (SCI) disrupts the connectivity between the brain and the spinal cord locomotor networks, leading to a
significant loss of motor control. Despite a dire need to develop ways to restore motor function after SCI,
treatment options remain limited. We recently demonstrated that the primary somatosensory cortex (SI) could
directly control the locomotor central pattern generator in the lumbar spinal cord via cervical excitatory
interneurons (SI locomotor pathway), independent of the motor cortex. Based on the paradigm-shifting discovery
that the sensory cortex can directly modulate spinal locomotor networks, this proposal aims to define the
mechanism of this sensory cortical control of locomotion and harness this pathway to restore walking after SCI.
First, in Aim 1, using a head-mounted miniature microscope, we will use circuit-specific single-cell resolution
calcium imaging of SI-cervical pyramidal neurons in freely moving mice. This strategy will allow us to identify and
decipher the neuronal activity patterns correlated to the initiation and speed of locomotion. Moreover, using a
circuit-specific optogenetic approach, we will determine if direct and specific stimulation of this pathway is
sufficient to initiate movement in health and after SCI. Aim 2 will determine this pathway's anatomical connectivity
and integrity using intersectional viral tracing experiments and comprehensive mapping of SI-cervical pyramidal
axon collaterals. In Aim 3, to determine the therapeutic potential of this pathway for locomotor recovery after
spinal cord injury, we will employ acute optogenetic and chemogenetic strategies. Overall, understanding the
functional significance of the SI-locomotor pathway and delineating the anatomical connectivity and integrity
post-SCI will enhance our knowledge of this newly discovered circuitry and facilitate the development of
strategies to restore movement after SCI and other neurological conditions with impaired movement.

Public health relevance
This project seeks to: 1) define the role of primary sensory cortical neurons in the initiation of movement, 2) determine the anatomical and functional integrity of the SI locomotor pathway, and 3) examine the therapeutic efficacy of modulating this newly characterized pathway for restoring walking after spinal cord injury (SCI). State- of-the-art cellular-specific optical imaging, optogenetics, and electrophysiology in freely behaving mice combined with viral tracing methods and chemogenetic neuromodulation will accomplish this proposal's objectives. Overall, a greater understanding of the anatomical organization and the functional significance of this novel sensory cortical-locomotor pathway will facilitate the development of new strategies to restore movement after SCI.